PROTEOMICS CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The mission of the INBRE Proteomics Core is to provide high quality, high-throughput, and cost-efficient proteomic and metabolomic services to all researchers in Nevada. The Core also provides services at preferred rates for researchers in the other IDeA states. Services available include 2D-gel electrophoresis, mass spectral analyses of proteins and small molecules, Edman degradation of proteins, and peptide synthesis. The Core functions on a fee for service re-charge basis for consumables. Except for specialized training courses, all analyses are carried out by Core personnel. The facility is located in 2 [unreadable]700 sq. ft. laboratory modules on the first floor of the Fleischmann Agriculture Building on the UNR campus. One lab is dedicated to 2D-gel electrophoresis and the other to mass spectrometry.